TSSK-dependent signaling pathway in spermatogenesis

ABSTRACT
Testis-specific serine kinases (TSSKs) belong to AMPK-related kinase family. Loss-of-function mutants of some
TSSK members lead to spermatogenesis defects in male mice, and several SNPs of TSSKs are associated with
male infertility in humans. However, the TSSK signaling mechanism during spermatogenesis is not understood.
This proposal employs Drosophila as a model system to investigate a novel kinase-substrate pair: TSSKs-class
IIa HDACs. Aim 1 will determine whether class IIa HDACs are substrates of TSSKs using both biochemical and
genetic approaches. Aim 2 will explore the functional relevance of TSSKs-class IIa HDACs during
spermatogenesis in Drosophila. Collectively, this proposal will establish class IIa HDACs as the key downstream
component of TSSK signaling.

Public health relevance
PROJECT NARRATIVE All five testis-specific serine kinases (TSSKs) are classified as understudied kinases by the “Illuminating the Druggable Genome” (IDG) consortium. This proposal aims to establish class IIa HDACs as functional substrates of TSSKs during the process of sperm development. Researches along this direction may not only elucidate TSSK signaling pathway, but also provide novel drug targets for male infertility.